Structure, function, and pharmacology of neuronal membrane transport proteins

Project Summary Membrane transport proteins are responsible for the passage of key molecules and the transfer of information across cell membranes, which are events central to many important neurobiological processes. They are designed to selectively recognize a variety of substrates of differing sizes and physicochemical properties for cellular transport. My overarching research goals are to understand the design principles of neuronal membrane transport proteins that are involved in pain and/or itch sensation and transmission, to develop pharmacological tools to modulate their function, and to apply the information gained from this research to exploit their therapeutic potential using a multidisciplinary approach including structural biology, electrophysiology, and pharmacology.

Public health relevance
Project Relevance Current treatments for debilitating chronic pain and itch conditions are limited. Our proposed structural, mechanistic, and pharmacological studies of neuronal membrane transport proteins will set a cornerstone for the future development of therapeutics to treat pain and/or itch-related disease conditions.